Oregon Healthy Workforce Center

PROJECT SUMMARY
The Oregon Healthy Workforce Center (OHWC) became the 4th NIOSH Total Worker Health® Center of
Excellence in 2011. The Oregon Healthy Workforce Center (OHWC) is located at Oregon Health & Science
University (OHSU) and directed by seasoned MPIs Hammer and Olson. The Center is represented by OHSU,
Portland State University, and the University of Washington, and engages in multiple collaborations and
partnerships, including with TWH Affiliates and other TWH Centers of Excellence. We provide outreach and
education to OSHA Region 10 (Oregon, Washington, Alaska, and Idaho) and have national and international
impacts. We address TWH research, practice, policy, and capacity building in the NIOSH TWH priority areas of
1) Measuring Worker Well-Being; 2) TWH Outreach, Education, and Training; 3) Opioid and Other Substance
Use Disorders in the Workplace; 4) Future of Work; 5) Healthy Work Design and Well-Being; and 6) Workplace
Mental Health and Worker Well-Being. Our theme is Total Worker Health® intervention effectiveness and
translation to advance safe and healthy work design. The NORA cross-sector of most relevance to our
theme is Healthy Work Design and Well-being. The mission of the OHWC is to provide TWH outreach and
education to our region while conducting research on interventions that impact workforce and population
safety, health, mental health, and well-being. Our intervention effectiveness studies are informed by current
research evidence, the hierarchy of controls applied to TWH, and relevant theoretical models appropriate for
the specific problems and populations we address. As a Center with strong expertise in Occupational Health
Psychology, our projects are informed largely by knowledge of psychosocial stressors and the understanding
that work is a strong social determinant of health. We view the assessment and control of physical and
psychological workplace hazards as the foundations for implementing expanded and integrated TWH
approaches to workplace interventions. We address the NIOSH Strategic Goal 7: Promote safe and
healthy work design and well-being. Our direction for 2021-2026 is to continue filling a critical gap in the
TWH intervention field by demonstrating strong, effective TWH interventions as evidenced by large effect
sizes, program sustainability, and continued development of partnerships to promote dissemination,
implementation and translation into practice by our outstanding Outreach Core. We advance four new
proposed research projects led by new and continuing PIs (Bowles, Huang, Hurtado/Lenhart, and Olson).
These include one large randomized controlled trial of an intervention to reduce burnout and improve well-
being among health care workers; one large assessment of a natural intervention evaluating the impact of work
schedule changes on firefighters’ mental health and well-being; one large translational research project to
extend our successful COMPASS intervention to address chronic pain among home care workers; and one
small etiological research project to develop and validate a TWH climate scale.

Public health relevance
PROJECT NARRATIVE The Oregon Healthy Workforce Center provides outreach and education to OSHA Region 10 (Oregon, Washington, Alaska, and Idaho) and has broader national and international research dissemination impacts. Our research projects contribute to our theme of TWH intervention effectiveness and translation to advance safe and healthy work design. These projects all employ organizational and individual change strategies linked to outreach, education and dissemination, and translation strategies to produce health, safety, and well-being changes that can be scaled and shared broadly.